MEDICAL IMAGING AND DATA RESOURCE CENTER (MIDRC)FOR RAPID RESPONSE TO COVID-19 PANDEMIC

Phase I: MIDRC COVID-19 Open Data Repository & Prototype Integrated Dashboard
Develop and maintain an open data repository that allows for rapid and flexible collection, analysis, and dissemination of COVID-19 related imaging and associated data.

Phase II: MIDRC COVID-19 Open Data Hybrid-distribution Repository & Clinical Integrated Dashboard
Expand the repository to create a centralized, hybrid-distributed data portal for real-world testing and implementation, for wider & rapid analysis and dissemination of COVID-19 related imaging and associated data, with clinically relevant algorithms